Label-Free Cell-Resolved Metabolomics for Tumor Microscopy

Summary
It is widely held that energy creation and use strategies employed by tumors may provide important diagnostic
and therapeutic opportunities. However, tools to directly and microscopically visualize these strategies do not yet
exist because most of the metabolites cannot be labeled for microscopy. This project uses recently developed
a coherent Raman imaging method that can rapidly obtain molecular vibration signatures of these unlabeled
metabolites, potentially making them visible. If the project is successful, it will yeild a microscope that will allow
cancer researchers and clinicians to, for the ﬁrst time, visualize metabolic activity in intact tumors, on a cell-by-cell
basis, and should facilitate discovery of new therapies and diagnostics.
Developing such an instrument presents signiﬁcant challenges. The project will approach these in our ﬁrst
Aim by developing a detailed theoretical model of our imaging approach, and testing it against a simpliﬁed and
well-controlled series of experimental tissue mimics. This dual model approach will allow us to discover the
most effective path to realizing the necessary instrument sensitivity and reliability. In the second Aim we test the
microscope in actual tissues and cell culture that is independently analyzed for content of metabolites measure
by BCARS.

Public health relevance
Narrative It is widely held that energy creation and use strategies employed by tumors may provide important diagnostic and therapeutic targets. However, tools to directly and microscopically visualize how these strategies are implemented by tumors do not yet exist. We will develop a microscope that will allow cancer researchers and clinicians to visualize metabolic activity in intact tumors on a cell-by-cell basis, and should facilitate discovery of new therapies and diagnostics.